The role of the extracellular matrix in establishing Schwann cell polarity

Abstract
Various cell types establish polarity to generate complex morphology and exert function. Schwann cells
(SCs) are polarized with an adaxonal membrane facing the axon and a basolateral membrane facing the
extracellular matrix (ECM). Previous work established that known polarity proteins, Par-3 and LKB-1/Par-4,
localize to the adaxonal membrane prior to myelination and are required within SCs for the timely progression of
myelination and Remak bundle formation. Although SC polarity is critical for proper peripheral nerve
development, the mechanism for establishing polarity within SCs remains unknown. The basal lamina, a
specialized structure of the ECM that abuts the basolateral membrane, is believed to be important for regulating
polarity; additionally, in other epithelial cells collagen-IV is necessary for the establishment of polarity. SCs
secrete collagen-IV into the basal lamina and express integrin alpha2, a collagen-IV receptor also known for its
role in polarity. Therefore, I hypothesize that collagen-IV initiates SC polarity by signaling through integrin alpha2
and is necessary for rSC polarity but dispensable for myelination. I test this possibility by analyzing the role of
SC secreted collagen-IV on peripheral nerve development, determining whether collagen-IV within the SC basal
lamina is necessary and sufficient for SC polarity, and identifying the SC binding partner for collagen-IV.
Preliminary data suggests that SC-secreted collagen-IV is important for timely myelination and Remak bundle
formation. These results phenocopy those observed when polarity is disrupted by knocking out LKB1 specifically
from SCs. Upon completion, this study will have important implications on the integration of extrinsic signals from
the ECM onto the internal cell state. Thereby regulating polarity, which is critical for peripheral nerve health.
Additionally, understanding the results and mechanisms of polarity defects can inform the understanding of
peripheral neuropathies. In order to perform these studies, I will learn various techniques including protein
biochemistry, including Western blot and co-immunoprecipitation, primary cell culture techniques, CRISPR-
based gene editing, mouse behavioral assays, and viral construction/purification/transduction under the
guidance of my sponsor Dr. Jonah Chan. I will receive additional training of career development skills such as
experimental design, presenting posters/presentations, manuscript writing, and manuscript reviewing through
my sponsor, classes within the UCSF Neuroscience Program, and workshops through UCSF Office of Career
and Professional Development. I am confident that the rigorous training I receive during my PhD at UCSF will
enable me to pursue my long-term goal of becoming a tenure track principal investigator within academia.

Public health relevance
Project Narrative The development of the peripheral nervous system is critical for proper motor function and sensory perception; however, loss of polarity in mouse Schwann cells leads to defects in timely myelination and Remak bundle formation, which can contribute to peripheral neuropathies and neuropathic pain. By understanding the interaction between extrinsic cues, from the extracellular matrix, and the internal state of Schwann cells, this study will allow us to better understand how Schwann cells interact with their environment to regulate myelination and Remak bundle formation.